Direct Methylation with [11C]CO2 for Production of Radiopharmaceuticals

Project Summary
Positron Emission Tomography (PET) is an imaging modality that can be used to visualize and
quantify functional changes and the distribution of molecular markers in the body. PET utilizes
molecules that are labeled with positron-emitting isotopes (radiotracers), which are typically
produced via automated synthesis modules. Carbon-11 (11C) is a particularly important PET
radionuclide, as virtually all organic molecules contain carbon atoms. Because 11C has the same
properties as carbon-12, labeling with 11C is extremely useful as a radionuclide for exploration
of molecules as PET radiopharmaceuticals for exploration of their in vivo properties (metabolism,
binding, pharmacokinetics, etc.). Furthermore, the short half-life of 11C (20.3 min) allows for the
possibility of multiple molecular imaging studies on the same day, simplifying the logistics and
recruitment for clinical research studies. Traditionally, 11C is installed with either [11C]Mel or
[11C]MeOTf as synthons due to their straightforward production from cyclotron-produced
[11C]CO2. Recently, researchers have begun to use [11C]CO2 directly to form ureas and
carbamates, but exploration into use of [11C]CO2 for methylation has been extremely limited. In
this proposal we will: 1) Develop and optimize direct use of [11C]CO2 reductive methylation
method for heteroatoms using a silicon-hydride reduction system. It is expected that this
approach will provide facile and rapid access to 11C-radiopharmaceuticals with a broad substrate
scope; 2) Develop a site-specific labeling method using iminophosphorances and [11C]CO2 that
will allow for 11C-methylation in the presence of multiple reactive sites; 3) Extend this direct
[11C]CO2 methylation methodology to carbon-nucleophiles to allow for direct carbon
methylation using [11C]CO2. Development of these radiosynthesis methods will allow for more
reliable and straightforward 11C-labeling strategies, reducing the development timeline for new
11C-radiopharmaceuticals and improving the radiochemical yields.

Public health relevance
Project Narrative Positron Emission Tomography (PET) is an imaging modality that uses radiolabeled molecules to visualize and quantify functional changes and the distribution of molecular markers in the body. Carbon-11 is a positron-emitting radionuclide that is extremely useful for PET because substituting it for carbon-12 in organic molecules enables in vivo study of their absorption, distribution, metabolism, and excretion. In this proposal we will develop radiosynthetic methodology that will enable direct use of [llC]C02 as a reactant for carbon-11 methylation, making carbon-11 radiotracers accessible in higher yields while eliminating the need for specialized carbon-11 processing equipment.